New Horizons in the Prevention and Treatment of Food Allergy

Leadership Center Summary/Abstract
Food allergy research has increased dramatically over the past 20 years, in large part to the efforts of CoFAR.
New approaches for both treatment and prevention have been introduced, as have the understanding of the
immunologic basis of food allergy. The overarching goal of the research agenda proposed in this application is
to maintain CoFAR's position as an international leader in the study of food allergy, including optimal
characterization of the disease and development of the next generation of treatments ad prevention. The
research agenda will be based first and foremost on the best possible science, but to maximize productivity we
will also need to plan judiciously so that all available resources can be used to their utmost capacity. Therefore,
the research agenda will need to carefully select and stage protocols based not just on their potential to advance
the field, but also with careful consideration regarding other novel treatments that may be under development,
and how one study may inform the next. Finally, the overall research strategy will need to work in unison with
the NIAID, the SACCC and each CRC in the consortium.
This overall agenda will be accomplished through the following major components: 1) To implement a leadership
team capable of providing optimal administration of the Consortium, including financial, operational, and
managerial aspects, as well as protocol development and implementation, data collection and analysis, and
publications and presentations, with judicious financial management. Dr. Robert Wood will lead this team, with
co-PIs Drs. Scott Sicherer and Supinda Bunyavanich. The team will include experts in clinical trials as well as
the laboratory study of food allergy. The team will also include a financial administrator as well as a highly
experienced grants management group at Johns Hopkins. The leadership team will work closely with the NIAID
and SACCC, together providing day-to-day management of all clinical operations within the consortium. 2) To
develop the necessary committee structure to guide and implement the Consortium's administrative and clinical
operations. 3) To develop a structure of financial management that will make optimal use of all CoFAR funds
and resources. 4) To integrate the Biomarker Facility into each clinical protocol.
It is anticipated that a minimum of 2 major protocols, including both clinical trials and non-interventional studies,
will be initiated and completed over the seven-year funding period, and this could rise to 4 or even 5 protocols
depending on the size, duration, and complexity of each study. If successful, this research agenda will define
not just the next 7 years of CoFAR, but will also establish the platform for the next decade(s) of food allergy
research.

Public health relevance
Narrative: Leadership Center Research Strategy The major objective of the Leadership Center is to oversee the scientific direction for CoFAR, as well as the financial, operational, and managerial aspects such that the next phase of the consortium, including both interventional trials and clinical studies, can be conducted in the most rigorous, safe, efficient, and fiscally sound manner possible. This will be accomplished through a seamless working relationship with the NIAID and the Statistical and Clinical Coordinating Center (SACCC), as well as each of the Clinical Research Centers (CRCs). The outstanding record of accomplishment and leadership of the Principal Investigators on this application will ensure that CoFAR remains a global leader in the food allergy research.